Therapeutic benefit of targeting neuroinflammation in spinal cord injury with a novel small molecule inhibitor of the RNA regulator HuR

Spinal cord injury (SCI) is devastating and most often affects younger Veterans. There is significant long-term
morbidity, a shortened life span, and a high financial burden. Because of the poor regenerative capacity of the
spinal cord, development of early interventions that minimize secondary tissue injury is a priority. A major
contribution to secondary tissue damage and the initiation of neuropathic pain is the inflammatory cascade
triggered by activated glial cells (microglia and astroglia). This cascade begins immediately after SCI with glial
release of cytokines, reactive species, and vasoactive substances. This secretome produces damage to
neurons, oligodendrocytes and other cells at and beyond the level of injury through direct cytotoxic
mechanisms or indirectly through the promotion of cytotoxic and vasogenic edema, vascular compromise, and
tissue ischemia. These inflammatory mediators also trigger pathways that lead to chronic pain. The
inflammatory cascade is further accelerated by glial production of chemokines which recruit peripheral immune
cells, including neutrophils and monocytes, within the acute phase of injury. A major driver of the initial glial
response is HuR, an RNA regulator that promotes expression of key inflammatory mediators through
posttranscriptional mechanisms. Inflammatory mediators such as IL-1β, IL-6, TNF-α and iNOS contain
adenine- and uridine-rich elements in the 3’ untranslated region (ARE) to which HuR binds and positively
regulates their expression. Our prior work in SCI shows that HuR is activated in the acute phase of SCI and
exacerbates injury when overexpressed in glia. Our team has developed a novel class of small molecule HuR
inhibitors that blocks induction of inflammatory mediators in glial cells. In a pilot study of SCI using a mid-
thoracic contusion model, we observed attenuation of clinical deficits and neuronal loss with the prototype HuR
inhibitor, SRI-42127. We also found that SRI-42127 reduced allodynic pain in a peripheral nerve injury model.
In this proposal we hypothesize that HuR drives expression of a pro-inflammatory and toxic secretome
by resident glia that is triggered in the early stages of SCI, and that inhibiting HuR will reduce
secondary tissue injury, improve motor outcome and reduce neuropathic pain. We propose 3 specific
aims: (1) Further characterize the beneficial effect of HuR inhibition by SRI-42127on SCI recovery, (2) Assess
mechanisms by which HuR inhibition improves recovery after SCI, and (3) Assess the contribution of glial HuR
to inflammatory responses and tissue injury in SCI. The long term objectives of this proposal are to advance
our small molecule HuR inhibitors as a therapy in acute SCI and to gain a mechanistic understanding of how
ARE-mediated post-transcriptional regulation impacts SCI (secondary tissue injury, motor recovery and
neuropathic pain). The innovation of this proposal is the investigation of a novel class of HuR inhibitors for
therapeutically targeting the acute inflammatory response in SCI and the mechanistic investigation of post-
transcriptional pathways (to date essentially unexplored) in SCI. The significance of this application is its
focus on a treatment approach that might eventually be used in the battlefield at the time of acute injury as our
preclinical studies indicate excellent and fast penetration of SRI-42127 into the central nervous system with
peripheral administration, and a mitigating effect on neuronal loss and neuropathic pain. The signfiicance
extends beyond SCI as the same HuR-regulated pathways drive neuroinflammation in other acute CNS
injuries (e.g. traumatic brain injury or stroke) and chronic neurological diseases (e.g. ALS and Alzheimers).

Public health relevance
Spinal cord injury (SCI) is a devastating event that affects younger Veterans and is associated with long-term disability including debilitating neuropathic pain. In the acute phase of SCI, secondary tissue injury and the initiation of chronic pain occur due to a robust neuroinflammatory response triggered by immune cells in the spinal cord. Because of the poor regenerative capacity of the spinal cord, interventions need to target this inflammatory response to maximize functional outcomes. Treatment must be immediate and at the time of injury. This proposal will investigate an inhibitor of HuR, a major protein that drives the neuroinflammatory response after SCI. This molecule can be given peripherally and it quickly suppresses induction of the inflammatory response. We will determine its ability to improve functional outcomes by blocking secondary tissue injury and chronic neuropathic pain after SCI. This research proposal is therefore directly relevant to Veteran health and has the potential to improve quality of life for those who have suffered SCI.